The Role of Akt in Cell Survival and Cell Growth

During the last 20 years, we have been characterizing mice with different Akt isoforms deficiencies for
survival, lifespan, and susceptibility to cancer at the cellular and organismal levels. The current renewal
application is focused on the systemic effect of Akt isoforms deletion in adult mice. First, the systemic
deletion of Akt1 and Akt2 as well as moderate to high doses of pan-Akt inhibitor in adult mice induces
intestinal damage, loss of body weight, and eventually mortality. Thus, in the first part of this grant
application we will delineate the mechanism of the intestinal damage and will employ approaches to alleviate
it. Second, we found a marked discrepancy between the systemic effect and cell autonomous effect of Akt1
or Akt2 deletion on tumor initiation, progression, and metastasis. These results underscore the importance
of determining the systemic effect of gene targeting for cancer therapy. We will delineate the mechanisms by
which the systemic deletions of Akt1 or Akt2 in adult mice exert their effects on tumor progression and
metastasis in mouse models of breast cancer.

Public health relevance
The PI3K/Akt signaling pathway is frequently hyperactivated in human cancers, and therefore is being targeted for cancer therapy. Pan-Akt inhibition or systemic deletion of both Akt1 and Akt2 induces adverse physiological consequences. Therefore, it is important to understand the cause of these adverse consequences in order to alleviate them and the contribution of the different Akt isoforms to the adverse consequences, and tumorigenesis.